Microbial and dietary control of intestinal epithelial differentiation by HNF4A

PROJECT SUMMARY
There is a significant gap in knowledge of how intestinal epithelial cells (IECs) adapt to both diet and
microbiota simultaneously, and the transcriptional regulatory mechanisms underlying this adaptation. Our long-
term goal is to understand how microbiota and diet communicate with the intestinal epithelium to regulate its
physiology. The objective of this proposal is to leverage functional genomic, genetic, and biochemical
approaches to identify the transcriptional and cellular bases of intestinal adaptation to microbiota and high-fat
diet. Our preliminary studies showed microbiota alter the response of IECs to a single high-fat meal, as high-fat
meal in germ-free mice induced enterocyte-specific transcriptional programs, while the same meal in
conventionalized mice suppressed those programs and stimulated intestinal stem cell-specific transcriptional
programs. This suggests that microbiota suppress intestinal stem cell differentiation into enterocytes, yielding
cells that mount differential responses to high-fat meal. Yet we do not know the effects of long-term high-fat
diet alone or in combination with microbiota on intestinal adaptation. We and others have shown that the
nuclear receptor transcription factor hepatocyte nuclear factor 4 alpha (HNF4A) is responsive to both
microbiota and high-fat diet, and is responsible for establishing enterocyte identity, positioning it as a potential
integrator of these external stimuli to regulate differentiation of IECs. We previously discovered that microbiota
suppressed HNF4A activity, but the mechanism of this suppression remains unknown. Our preliminary data
showed that microbiota enhanced Protein Kinase A (PKA) activity and interaction with HNF4A. Further, we
observed HNF4A is phosphorylated at a PKA regulated site to disrupt DNA binding in IECs. We will test our
central hypothesis that high-fat diet and microbiota interactively suppress intestinal stem cell differentiation into
enterocytes by inhibiting HNF4A through PKA. First, we will determine if microbiota and high-fat diet
interactively suppress intestinal stem cell differentiation into enterocytes through HNF4A by using single-cell
RNA-seq and histology in Hnf4afl/fl and Hnf4aDIEC gnotobiotic mice fed a high-fat or low-fat diet. Second, we will
determine if microbiota suppress HNF4A through PKA by administering a pharmacological inhibitor of PKA to
gnotobiotic mice and utilizing biochemical techniques to track alterations in HNF4A phosphorylation, DNA
binding, and target gene expression. The expected outcomes will vertically advance the field in several ways.
First, they will expand our knowledge of how microbiota and high-fat diet interactively regulate the abundance
and transcription of IEC types, and the role of HNF4A in adaptive IEC differentiation. Second, they will identify
molecular mechanisms by which microbiota regulate HNF4A activity, which can lead to new tools to activate
HNF4A activity. These results would have a positive impact on our field by discovering mechanisms by which
the intestine adapts to diverse stimuli and identifying drugs to modulate intestinal physiology to treat disease.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because uncovering mechanisms by which the intestine adapts to both microorganisms and dietary nutrients simultaneously is expected to expand our understanding of how the intestine fundamentally responds to many perturbations, such as surgery, infection, malnutrition, and diseases like inflammatory bowel disease. Additionally, these findings are expected to identify a pharmaceutical tool that will potentially treat or prevent inflammatory bowel disease. The proposed research is therefore relevant to the part of NIH’s mission that pertains to developing fundamental new knowledge and applying it to enhance health and reduce disease burdens.